The Role of Microglia in Adolescent Ethanol-Induced Corticolimbic Damage

Project Summary
Excess alcohol use in adolescence is associated with negative health consequences including corticolimbic
damage and cognitive deficits. However, the mechanisms underlying these negative sequelae are not well
understood. Microglia, macrophages that reside within the brain, are activated in both humans and animals
exposed to alcohol. Activation of microglia to a proinflammatory phenotype can lead to tissue damage and is
thus considered a possible cause of adolescent corticolimbic damage following ethanol exposure. Interestingly,
we do not see evidence of a proinflammatory microglial phenotype concomitant with corticolimbic pathology in
binge ethanol exposed rats. Given that microglial function is more complex than previously appreciated, we
consider instead that microglia may serve a neuroprotective role following exposure to ethanol. To test this
hypothesis in Aim 1 adolescent rats will be exposed to 2 days of binge ethanol following by microglial
morphological and transcriptomic analysis to characterize activation state. Microglia will then be depleted prior
to, throughout, and following ethanol exposure using a CSF1R antagonist to determine the effects on markers
of neurodegeneration and cognitive function. Interestingly, microglia are known to exhibit a form of immune
memory by which prior exposure results in altered responsivity to future activation. We hypothesize that
persistent changes to the microglial set-point underlie exacerbation of corticolimbic pathology with repeat
exposure to ethanol. In Aim 2 adolescent rats will undergo 2 days of binge ethanol exposure followed by microglia
depletion and repopulation before another 2 days of binge ethanol exposure. This replacement of the microglia
population may serve to reset these cells to a baseline phenotype. We expect (1) that rats exposed to both
ethanol binges will show greater microglial activation, corticolimbic neurodegeneration and cognitive deficits
relative to a single 2-day binge ethanol exposure, and (2) that forced microglia turnover will ameliorate these
effects. In combination, these aims will significantly enhance our understanding of role that microglial activation
and memory play in corticolimbic neurodegeneration following exposure to ethanol.

Public health relevance
Project Narrative Adolescence is developmental window during which high levels of alcohol consumption frequently occur. Unfortunately, the adolescent brain is also highly susceptible to alcohol induced damage and associated behavioral deficits. The goal of this project is to understand the role of activated microglia, a type of immune cell residing in the brain, in the tissue damage seen following exposure to alcohol in adolescent rats. Targeting the activity of these cells is a promising therapeutic strategy in alcohol use disorders.